An Efficacy Trial of Community Health Worker-Delivered Chronic Pain Self-Management Support for Vulnerable Older Adults

Chronic pain is an enormous public health problem. Evidence-based chronic pain self-management support can improve pain-related functioning, yet standard models for providing this support are not well-suited to reach broad groups of older people. Existing pain self-management interventions are mostly group-based and require in-person contact, making them less accessible to older adults with transportation or mobility barriers. Moreover, existing interventions seldom address unmet social needs that can exacerbate pain and hinder its management. The long-term goal of this line of research is to build a robust evidence base for chronic pain self-management interventions that meet the needs of older adults who have barriers to accessing, or benefiting from, standard CPSM. The objective of this proposed project is to determine whether community health workers (CHWs)—i.e., lay health workers with close ties to the communities they serve – can effectively teach cognitive-behavioral pain management strategies to older adults. CHWs are uniquely suited for this role, given their ability to form a therapeutic alliance with patients and their deep knowledge of community resources that enables them to address social needs. The central hypothesis is that a CBT-based pain self-management intervention (“STEPS”) delivered over 7 weeks through telephone sessions with a CHW and mobile health tools improves one-year pain-related outcomes. Our highly encouraging preliminary findings indicate that STEPS is feasible, deliverable by CHWs with high fidelity, and well-received by participants (n=31). Its potential efficacy is suggested by significant improvement in pain interference (pre-post Standardized Mean Difference = 0.84, p = 000). The proposed trial will take place in partnership with the Detroit-based Henry Ford Health System. There are three specific aims: 1) Conduct a Stage 3 efficacy trial to assess whether STEPS can reduce one-year pain interference and intensity among 414 older adults; 2) Assess psychobehavioral mediators and moderators of intervention effects; and 3) Using qualitative data from participants and other stakeholders, conduct mixed-methods analysis to provide context for quantitative findings and inform a toolkit for dissemination, if the intervention is effective. This project is innovative in that it enlists CHWs, who have delivered evidence-based interventions for other conditions but are not yet part of the pain care workforce. It has strong potential impact given that the model being tested is low-cost, scalable, and suitable for settings where the prevalence of chronic pain is greatest. Moreover, it can be delivered remotely, which maximizes access. Ultimately, this research could lead to a transferable model that can be applied to other populations in need of improved pain care.

Public health relevance
Expanding opportunities to learn chronic pain self-management skills is a major public health priority, yet we lack evidence for successful delivery models in older populations who may not be able to access traditional programs. We will test a program in which community health workers teach pain self-management skills to older adults. Because older adults are at disproportionately high risk for poor functioning due to pain, this research could substantially enhance population health.